Mechanistic Elucidation and Targeted Therapy of Organ Injury and Inflammation following Trauma

Project Summary/Abstract: Multiple organ dysfunction syndrome (MODS) is a leading cause of death after
severe trauma, which is a leading cause of mortality worldwide. MODS is thought to be a consequence of a
vicious cascade of excessive inflammation and coagulation abnormalities but remains incompletely
understood. Recent advances in the resuscitation of trauma patients (such as whole blood transfusion and the
use of tranexamic acid) have led to improved initial survival, yet these critically ill patients now stay alive to be
at risk to develop MODS and other immune/inflammatory complications. This makes understanding how
MODS occurs a critical and an immediate need in trauma. MODS is thought to arise in the setting of excessive
innate immune activation and is associated with the late phase of trauma-induced coagulopathy (TIC). TIC is
characterized by endothelial injury, excessive thrombosis manifesting as both severe small vessel thrombosis,
which contributes to organ dysfunction, as well as deadly large vessel thromboembolic events. There is a
critical need to identify a mechanistic link between the excessive inflammatory and innate immune responses
and the defects in coagulation in order to understand MODS.
The overarching goal of our research is to understand how trauma leads to organ injury through
inflammation and clotting of blood vessels, or immunothrombosis. Our research focus is the central role of
platelet function in driving immunothrombosis after trauma. Our preliminary data demonstrate that platelets are
critical to the innate immune response after injury. Platelets are sentinel cells in immune function and serve a
critical regulatory function by interacting with other inflammatory cells, and in this way are a major link between
inflammation and thrombosis. Furthermore, trauma-induced `dysfunctional' platelets are key components to
both drive TIC and to amplify inflammation and organ injury. Thus, we hypothesize that dysfunctional platelets
and their interactions with other immune cells are critical regulators of MODS. There is an imminent need to
develop research focusing on the prevention and management of organ injury and complications of
inflammation/thrombosis, and this represents the key theme of the present proposal and research program.
Furthermore, modern trauma resuscitation is rapidly changing to include new techniques which saves lives
after injury. We must understand exactly how these interventions work to design the next great advance in
resuscitation and also how they impact the risk of MODS. Essential to this is the need to develop targeted
therapeutic strategies to treat the overwhelming morbidity after trauma.
We propose to tackle the following key knowledge gaps in the field:
1) Understand the cellular mechanisms leading to micro-thrombotic organ injury in survivors after trauma
2) Unravel the immune and inflammatory consequences of modern trauma resuscitation
3) Design targeted interventions for post-traumatic organ injury and thrombosis

Public health relevance
PROJECT NARRATIVE Multiple organ dysfunction (MODS) is a leading cause of death and disability after trauma. The mechanisms promoting MODS after trauma are largely unknown but are believed to involve excessive activation of the immune system as well as the formation of small blood clots in organs such as the lungs and kidneys. This program will 1) examine how trauma-induced MODS occurs with particular emphasis on how platelets regulate immune function and thrombosis 2) characterize immune and inflammatory consequences of modern trauma resuscitation and 3) design targeted assays to reduce MODS and target platelet dysfunction.